Novel Immunomodulators for Melanoma Therapy

PROJECT SUMMARY
As estimated by the National Cancer Institute, there are more than 900,000 people living with melanoma in the
USA. Despite recent advances in melanoma drug discovery, the average overall survival of patients with late-
stage metastatic melanoma is ~3 years. Instances of complete response are very rare; therefore, more life-
prolonging therapies are needed. This suggests a need for new approaches and targets for melanoma drug
discovery.
Our recent in vivo proof-of-principle efficacy and toxicity studies using small molecules discovered by us
demonstrated that spliceosomal proteins hnRNPH1 and H2 (H1/H2) can be targeted without overt and organ
toxicity to induce melanoma-specific cell death that can address an unmet need for such novel therapeutic
approaches. Additionally, our preliminary data suggest that modulation of H1/H2 expression in melanoma cells
in vitro upregulates immunogenicity of melanoma cells and induces infiltration of immune cells in vivo which can
be used for immunotherapy.
Based on these considerations, we hypothesize that targeting of H1/H2 could be a much needed and effective
broad-spectrum melanoma therapy. To test this hypothesis, we propose to (1) determine efficacy of spliceosomal
inhibitors 2155-14 and 18 in in vivo models of human TWT melanoma, (2) determine the role of H1/H2 in human
melanoma intra-cellular immune pathways, and (3) validate immune response to H1/H2 treatment in vivo in
BRAF and NRAS murine melanoma models. Our team is uniquely positioned to successfully execute the Aims
of this study. Profs. Minond and Beljanski have expertise in drug evaluation in animal and molecular studies.
Overall, these studies will validate targeting spliceosomal proteins hnRNPH1 and H2 as a useful approach to
melanoma targeted and immunotherapy.

Public health relevance
PROJECT NARRATIVE Our recently discovered small molecules are active against melanoma in mice models are and non-toxic. We are proposing to test these leads compounds in additional models to test the feasibility of a new therapy approach and determine their mechanism of action.